Effects of Intermittent Fasting on Glycemic Control in Patients with Diabetes

Intermittent fasting (IF) is an alternative to daily calorie restriction for producing clinically relevant weight loss.
Though intermittent fasting does not increase weight loss relative to daily calorie restriction, modifying the
timing of food intake via intermittent energy restriction (IER) or time-restricted eating (TRE), two forms of
intermittent fasting, may provide a pronounced benefit to glycemic control. However, these two IF approaches
have not been thoroughly tested or compared in patients with type 2 diabetes (T2D). Further, pancreatic beta
cell responsiveness and insulin action in response to a mixed meal depend on a functionally normal incretin
axis. Two insulinotropic peptides, glucose-dependent insulinotropic polypeptide (GIP) and glucagon-like
peptide-1 (GLP-1) are essential for postprandial glucose control. Incretin-stimulated insulin action contributes
more than 70% of the insulin response to a meal in healthy adults, overshadowing the effect of glucose alone
to stimulate insulin secretion. In patients with type 2 diabetes, the incretin response is blunted, contributing to
poorer glycemic control. Similarly, higher levels of inflammation blunt insulin sensitivity. Intermittent fasting
reduces inflammation and improves incretin expression in mice, however these effects have yet to be
replicated in patients with T2D. Our goal is to evaluate potential mechanisms of benefit for two IF approaches
on glycemic control in patients with T2D. The primary aim is to determine the effects of two forms of
intermittent fasting on insulin action and whole-body insulin sensitivity. We will also compare changes in body
composition between IER and TRE and conduct the first trial to determine the effects of both intermittent
fasting approaches on the incretin response to a meal. In exploratory analyses, we will phenotype individuals
based on metabolic assessments to determine potential predictors of response from each intervention. We will
do this by leveraging and supplementing an existing randomized controlled trial utilizing both IF approaches
within a 6-month multicomponent lifestyle change program incorporating a comprehensive health education
program for diabetes via biweekly group meetings delivered remotely. Primary endpoints will be collected at
weeks 0, 12, and 26, and 52 weeks. In addition to data already being collected on weight change, glycemic
control via HbA1c and continuous glucose monitoring, we will conduct a 3-hour, 9-point mixed meal tolerance
test (MMTT) with glucose, insulin, and c-peptide to allow for estimates of insulin secretion and pancreatic beta
cell function. Additionally, we will assess the effects of IER and TRE on body composition, incretin response
and inflammatory cytokine levels during the 12-month intervention. Mixed models with repeated measures
analysis will be used to assess the effect of each approach on outcome measures and, secondarily, to
compare these two forms of IF. The long-term goal of our research is to determine whether intermittent fasting
approaches are an effective alternative to standard of care for diabetes treatment. Secondarily, our goal is to
determine which patients are most likely to benefit from either intermittent fasting regimen.